Delineating mechanisms of skeletal fragility in older adults with Type 1 Diabetes

PROJECT SUMMARY
The current proposal is a competitive revision for the recently funded R01DK124710 that will expand the scope
and potential impact of the parent grant. Skeletal fragility is a recognized complication of Type 1 diabetes (T1D)
and is of particular concern among older adults. However, the mechanisms underlying skeletal fragility are poorly
understood. While vascular deficits are a well-known complication of diabetes, their effect on bone blood flow
regulation has not been explored. Thus, this proposal seeks to investigate the contribution of diabetes-induced
vascular deficits on bone circulation and skeletal fragility within the cohort of older adults of the parent grant.
Using a novel approach, near infrared spectroscopy (NIRS), we will non-invasively assess tibial blood flow in
humans and on a moment-by-moment basis. Employing NIRS, Aim 1 will investigate whether older adults with
T1D have lesser myogenic vasodilation and greater myogenic vasoconstriction in the tibial vasculature compared
to nondiabetic controls. Aim 2 will explore whether older adults with T1D have blunted nitric oxide (NO)-mediated
vasodilation in the tibial vasculature compared to nondiabetic controls. Furthermore, Aim 3 will explore the
relationship of tibial vascular responses (myogenic vasodilation, myogenic vasoconstriction, NO-mediated
vasodilation) to microvascular disease burden, peripheral vascular calcification, and glycemic control in older
adults with T1D. Lastly, Aim 4 will investigate the relationship between tibial vascular responses and tibial
microarchitecture among older adults with T1D. We have assembled a highly interdisciplinary team with
complementary expertise to perform this study and we will leverage the existing study cohort of the parent grant
in a highly cost-efficient manner; several assessments of the parent grant will be utilized in the current proposal
and the patient burden will be minimal, requiring a single study visit. The proposed research will provide the first
ever characterization of in vivo bone blood flow regulation among adults with T1D and will add invaluable insight
into how vascular complications may compromise bone structure and strength in older adults with T1D.
Successful completion of this project will provide the foundation for future work towards novel treatments for
bone health in older adults with diabetes.

Public health relevance
PROJECT NARRATIVE Despite the critical importance of blood flow to bone health, it is unknown how diabetes-related vascular deficits impact bone blood flow and contribute to skeletal fragility in older adults with type 1 diabetes (T1D). Using near infrared spectroscopy (NIRS) to assess tibial blood flow non-invasively, we will investigate key mechanisms of bone blood flow regulation and their contribution to bone deficits in older adults with T1D. The outcome of the proposed research will allow us to characterize for the first time the link between bone blood flow and skeletal fragility in diabetes and will provide unique mechanistic insights for future work towards novel treatments for bone health in older adults with T1D.